Translational models of neurodevelopmental epigenetics and disease using human iPSCs

PROJECT ABSTRACT – Project 3 N/A per PAR-14-183

Public health relevance
PROJECT NARRATIVE – Project 3 N/A per PAR-14-183